GSA MENTORING AND CARREER DEVELOPMENT TECHNICAL ASSISTANCE WORKSHOP

PROJECT SUMMARY/ABSTRACT
For 75 years, the Gerontological Society of America (GSA) has changed, impacted, advanced,
and empowered the scientific and scholarly study of aging. It has effectively promoted human
welfare by integrating and expanding gerontology sciences in all its areas. The GSA annual
scientific meeting (ASM) emphasizes research, education, training, and policy related to the
biological, psychosocial, and behavioral aspects of health, disease and human rights impacting
the sciences of aging and human lifespan. The GSA ASM features an outstanding educational,
scientific program and social events designed to promote cross-disciplinary exchange and
dissemination of multidisciplinary aging research. One of the society’s overarching aims is to
cultivate the professional development of early career professionals and students at its annual
meeting through engagement in diverse educational outlets.
We are proposing a NIA Research Conference Grant (R13) entitled “GSA Mentoring and Career
Development Technical Assistance Workshop” to support early career trainees (pre- and post-
doctoral) from underrepresented minority (URM) backgrounds to participate in a pre-conference
technical assistance workshop series to be offered at the GSA ASM from 2021-2025. The
workshop series is designed to promote training, education, networking, and the interaction
between diverse URM trainees, mid-, and senior level investigators who have prominent
leadership roles in the field of gerontology. To accomplish the proposed objectives and goals of
this research conference grant, we will develop recruitment approaches, training, mentoring,
evaluation, dissemination, and sustainability of the workshops (Aim 1); implement the GSA
MCD TAWs annually for five years and provide travel award support for 100 trainees (Aim 2);
we will regularly evaluate (and modify as needed) the workshops’ curriculum, faculty, trainees
and ongoing educational and mentoring activities delivered via surveys, webinars, focus groups,
and emailed questionnaires (Aim 3); we will facilitate dissemination of the workshops’
curriculum, outcomes, outputs and evaluation results via social media, webinars, lectures, white
paper reports, peer review publications, and presentations at scientific meetings (Aim 4).
We are requesting support from the NIA to assist with the recruitment, inclusion, and training of
talented early career investigators from URM backgrounds to receive travel fellowship awards to
participate in the GSA MCD TAW series. The travel awards will help trainees with hotel,
transportation, registration, and family care (i.e. childcare) expense.

Public health relevance
PROJECT NARRATIVE This R13 Research Conference application seeks funding to support pre- and post-doctoral level trainees from under-represented and diverse backgrounds to participate in a mentoring and career development pre-conference technical assistance workshops (MCDTAWS) at the annual scientific meetings of the Gerontological Society of America (GSA) from 2021 to 2025. This unique mentoring and career development training program is tailored to suit the needs of URM trainees interested in pursuing a career in gerontology. We are requesting support from the NIA to assist with the recruitment, inclusion, and training of talented trainees from URM backgrounds to participate in the GSA MCDTAW series.